Investigating and Characterizing Non-Viral, Biocompatible Delivery Vehicles for Nucleic Acid Nanoparticles

PROJECT SUMMARY
Nucleic acid nanoparticles (NANPs) have the ability to simultaneously deliver a cocktail of multiple
therapeutic nucleic acids (TNAs) that can treat diseases by targeting several biological pathways. However, in
order to be functional, NANPs require a delivery vehicle to enter cells while being protected from naturally
occurring nucleases.
There have been studies showing that amine-terminated polyamidoamine (-NH2) PAMAM dendrimers
have successfully delivered TNAs such as small interfering RNAs, and micro RNAs into cells while efficiently
protecting them, but these studies deep dive into only one generation of dendrimers. This proposal aims to
investigate and compare five different generations of (-NH2) PAMAM dendrimers to interpret how each will
behave as a carrier for several representative NANPs.
A second delivery platform that will be investigated are exosomes that are harvested from cancerous and
non-cancerous human cell lines. Exosomes naturally pass biological information from cell to cell and we would
be utilizing this natural communication machinery to deliver NANPs. Each exosome carries different biomarkers
corresponding to the cell line of origin, and these biomarkers can be used to identify the exosome type and tune
their biodistribution, immunorecognition and cellular uptake. Along with exosomal identification, the type of the
NANP embedded into the exosome complex may additionally contribute to their biological behavior, which is
what we would like to investigate in this current proposal.
Once competed, this investigation will supply information regarding the role that synthetic and naturally
occurring vehicles have on immune response and efficacy, as well as how NANPs' architectural parameters
(e.g., 3D vs 2D vs 1D) influence their delivery and immune response. The broad and long-term objectives for
this work would be to categorize a database focused on the in vitro behavior of NANPs complexed to their
vehicles to include the immune response, protection, and efficacy of the NANP-carrier platform. In collecting this
data, and compiling it, future nucleic acid based therapeutics could be rationally designed with specific
parameters and tailored immune recognition and function based on what a patient requires.
All proposed experiments will be completed by the applicant who will collaborate with the necessary
personal to learn any supplemental techniques needed. In addition to completing the proposed work, the
applicant will be serving as a leader in more than one graduate organization where the applicant will be gaining
professional, communicative, and leadership skills needed to network when presenting this work at conferences.
The University of North Carolina at Charlotte is a space that is experiencing exponential growth that is focused
on student success and provides valuable resources for students and researchers to utilize.

Public health relevance
PROJECT NARRATIVE The field of nucleic acid nanotechnology is being increasingly investigated with promising potential to target and treat a myriad of illnesses that can range from being genetic to viral infections. In this surge of growth, nucleic acid nanoparticles (NANPs) have been developed to effectively deliver a cocktail of treatments all on one nanoparticle that is also designed to possess controlled immunostimulation and physicochemical properties. Dendrimers and exosomes that are biocompatible, non-viral vehicles have shown to effectively deliver NANPs, which otherwise cannot be internalized into cells, and will now be investigated as a vehicle for functional NANPs.